Toxicity Study of the Serotype 2 Adeno-Associated Viral Vector hAQP1(rAAV2hAQP1)

Study to Evaluate the Pregnancy Rate in Harlan Sprague Dawley Rats from Two Harlan Facilities and to Evaluate Gene Expression Data